An mHealth implementation strategy to address the syndemic of mental illness, hypertension, and HIV in Uganda

There are 38 million people living with HIV (PLWH) worldwide, 68% of whom live in sub-Saharan Africa. With
the transition of HIV from an acute illness to a chronic condition, co-morbid non-communicable diseases (NCDs)
such as depression and anxiety disorder, alcohol use disorder (AUD), and hypertension (HTN) have become
epidemic among PLWH. Despite evidence-based interventions to promote integration of these HIV comorbidities
into HIV service delivery, integration efforts face challenges. First, integration commonly fails to recognize the
syndemic relationships between these conditions and the deleterious effect of social factors such as poverty,
stigma, and lack of access to care that worsen their outcomes, especially in low- and middle-income countries.
Second, integration commonly imposes additional clinical tasks upon overburdened healthcare workers (HCW)
operating in busy clinical environments without private space needed to attend to these additional conditions that
are often stigmatized. A syndemic approach, which explicitly integrates the biological and social interactions that
cause these conditions to cluster, has been proposed as a means of addressing the complex needs of PLWH.
Mobile health (mHealth), an evidence-based strategy that leverages the widespread penetration of mobile
phones to relieve HCW of burdensome tasks while enabling their systematic, consistent implementation, has
been proposed as a solution to address HIV-related syndemics, but this approach has not been tested. Our
exemplary multidisciplinary team has a strong track record of collaboration. In the current proposal, which
leverages the infrastructure of an ongoing implementation study of HIV/HTN integration in Uganda, we will
pursue these Specific Aims: Aim 1) Adapt Medly Uganda for detection, linkage to care, and ongoing support of
depression, anxiety disorder, and AUD among Ugandans with HIV and HTN using a syndemic approach.
Through human-centered design (HCD), we will engage patients, caregivers, and professional/lay HCW to guide
iterative adaptation of Medly Uganda with explicit attention to common biosocial drivers. The adapted application
will integrate widely used (1) screening instruments along with validated measures of significant life events,
economic shocks, and stigma, (2) algorithm-driven messaging and alerts, and (3) linkage to HCW for support
and treatment. We will also develop and operationalize a novel syndemic care cascade (R21 phase); Aim 2)
Assess the effectiveness of the Syndemic-Adapted Medly Uganda (SAMU) to improve mental health care
cascade metrics by conducting a single-arm trial using real-world historical data (R33 phase); Aim 3) Evaluate
the factors impacting sustained engagement in the adapted Medly Uganda using mixed methods (R33 phase).
Throughout the study period, we will focus on strengthening our Uganda-based team's mHealth research
capacity and furthering our partnerships with government officials to ensure that SAMU can be locally maintained
and sustained. The proposed study addresses a high priority topic for use of AIDS-designated funds at NIH and
aligns with multiple National Institute of Mental Health priorities as described in PAR-21-303.

Public health relevance
PROJECT NARRATIVE There is strong evidence to support a syndemic of depression, anxiety disorder, alcohol use disorder, hypertension, and HIV. In the proposed study, we will use a syndemic approach to adapt Medly Uganda- a mobile health platform developed and tested by our team- to address this syndemic using evidence-based strategies. We will use a human-centered design approach to develop Syndemic-Adapted Medly Uganda (SAMU), will conduct a clinical trial to assess its effectiveness at improving key mental health care cascade outcomes among patients living with HIV and hypertension in Uganda, and use mixed methods to evaluate engagement with SAMU.